Genetic Predictors of Response to mTOR inhibitors in advanced Renal Cancer

DESCRIPTION (provided by applicant): The mechanistic Target of Rapamycin (mTOR) inhibitors (temsirolimus or everolimus) are standard options in advanced renal cell cancer (RCC). Despite the obvious clinical benefit compared to the control arms from the phase 3 registration trials (IFN-α or placebo), these drugs are expensive, can carry significant toxicities and most important, responses are usually short-lived. At present, there are no clinically useful predictive biomarkers of response or resistance to targeted therapy in metastatic RCC. Several lines of evidence suggest that treatment outcome is likely to be determined by particular genetic alterations and signaling pathways activated in individual tumors. In a preliminary experiment on 11 tumors from RCC patients who responded to temsirolimus, we noted that 6 of the 11 (55%) responders had a variant in 1 or more mTOR pathway genes. This compares to a background of ~15-20% mTOR pathway mutations in an unselected RCC population. Our first aim is to identify genetic predictors of response to agents targeting the mTOR pathway in RCC using targeted sequencing of all RCC and mTOR pathway genes. Our second aim is to identify acquired mutations that develop in tumors that initially respond to mTOR inhibitors and then progress, using whole exome sequencing of matched pre and post-progression samples. Our long term objective is to perform a definitive test of the hypothesis that mTOR pathway mutations are associated with clinical benefit to rapalogues in RCC. In term of public health significance, our work should allow us to identify those patients with the highest chance of benefit to mTOR inhibitors, and enable an understanding of mechanisms of resistance to these therapies; thereby we will improve both the survival and quality of life of patients with advanced RCC by developing an individualized therapeutic approach. Our project is likely to translate into clinical application within a short period of time and be of major relevance to the field of kidney cancer, a disease that results in more than 13,000 US deaths annually.

Public health relevance
PUBLIC HEALTH RELEVANCE: mTOR inhibitors are a class of agents that are approved for treating metastatic kidney cancer, which causes more than 13,000 US deaths annually, but the benefit of these drugs for each patient is highly variable. The first part of this proposal is to ue genetic analysis of kidney cancers to develop methods to identify those patients who will respond to mTOR inhibitors vs. those who will not respond. A second part of this work is to try to understand mechanisms of resistance to mTOR inhibitor treatment, when it develops. If successful, our findings will enable personalized therapy in RCC directed at those patients most likely to respond to mTOR inhibitors, and avoiding unnecessary treatment delay and toxicity in those who are not likely to benefit.